CRH AND CRH RECEPTOR TESTING IN ISOLATED ACTH DEFICIENCY

This studyseeks to determine whether the response to ovine CRH (oCRH) is abnormal in a family whose child is followed at CHOP for isolated ACTH deficiency.